Vascular MicroRNA-212 in CAA and Alzheimer's disease

Supplement Summary and Aims
The funded grant aims to determine the role of microRNAs (miRNAs) in post-
transcriptional regulation in the context of cerebrovascular dysfunction and blood-brain-
barrier (BBB) disruption, particularly within Alzheimer's disease (AD) and cerebral
amyloid angiopathy (CAA). AD is characterized by an accumulation of amyloid-β (Aβ)
plaques and neurofibrillary tangles, with cerebrovascular dysfunction (CVD) and
neuroinflammation playing key roles in the progression of the disease. In fact, most cases
of AD exhibit Aβ deposition in and around cerebral blood vessels, thus presenting an
additive effect to the pathology of the disease.
The BBB, composed mainly of endothelial cells (ECs), regulates the entry of circulating
substances from the blood to the brain and assists in clearing harmful molecules from the
brain, including oligomeric Aβ. Disruption of the BBB and the accumulation of Aβ in and
around cerebral blood vessels is associated with changes in ECs, yielding a
proinflammatory phenotype and leading to apoptosis. In our preliminary data of the parent
grant, we have found that miRNA-212 is decreased in ECs treated with Aβ. Previously,
we have shown that Aβ treatment leads to EC apoptosis and increase in EC barrier
permeability. We have shown in our preliminary data that several genes involved in EC
apoptosis contain binding sequences for miRNA-212.
Our overarching goal is to test the hypothesis that Aβ promotes cerebrovascular
dysfunction and BBB failure via endothelial cell miRNA-212.
To achieve our goal, during this Supplement I specifically aim to accomplish the following
Aims. Aim 1: measure miR-212 levels in exosomes released from ECs under the same
Aβ conditions as in Aim 1 of the Grant. The release of miRNAs via exosomes may be
essential for regulation in nearby cells of the neurovascular unit and may serve as a
biomarker for AD and CAA diagnosis and progression. Aim 2: assess the impact of miR-
212 downregulation and rescue on BBB permeability in neurovascular unit complex
systems. To ascertain the role of miRNA in CVD and BBB loss of function.

Public health relevance
The vascular contributions to cognitive impairment and dementia are well recognized mediators of Alzheimer's disease and related disorders, and endothelial cells are essential players in the vascular pathology due to their role of gatekeepers of the blood-brain barrier (BBB). Micro RNAs are short non-coding RNAs that regulate cell survival and function, but their role as contributors to endothelial cell stress and death mechanisms as well as BBB permeability in AD and cerebral vascular amyloidosis is largely unknown. Here, through the use of human endothelial cells in culture and vessels purified from mouse and human brains with vascular amyloid deposits, we plan to test the hypothesis that the miR-212 downregulation induced by Amyloid β contributes to BBB failure and neurovascular dysfunction in AD and related dementias.